Long-term health-related quality of life and cost of allogeneic hematopoietic cell transplantation for children with sickle cell disease

Project summary:
This project performs an innovative, integrated analysis of clinical, health policy, and health economic questions
relevant to curative treatments for sickle cell disease (SCD) using cost-effectiveness analysis of a prospective
patient cohort. The project is timely and of great significance to individuals, providers, and health systems as the
rapid advances in the field of allogeneic hematopoietic cell transplantation (alloHCT) for SCD now warrant further
investigation of this treatment option in the context of a varied landscape of therapeutic options for SCD.
Specifically, critical improvements in supportive care have improved the safety and efficacy of alloHCT for SCD
from a matched sibling donor (MSD) resulting in a dramatic increase in the acceptability of such transplants. This
has resulted in the emergence of efforts to expand the availability of alloHCT to individuals without a MSD using
alternate donors. At the same time, health policy is changing the landscape for alloHCT and curative therapies
for SCD. In 2016, CMS included alloHCT for SCD in the national coverage determination with continued evidence
development including focus on case control studies and quality of life assessment. Therefore, we have a clear
mandate to understand the implications of alloHCT on health, quality of life, finances and service utilization in
the short and long term compared to established conventional therapies. This K23 proposal plans to address
this gap in understanding with a comprehensive cost-effectiveness analysis (CEA) according to the following
steps: 1) define transition probabilities from published literature to serve as benchmarks or reference cases for
our prospective analysis 2) use a novel methodology to translate prospectively collected PROMIS measures
surveyed in the STELLaR study into preference based utility scores necessary for CEA 3) obtain prospective
adjusted costs for STELLaR cases and controls 4) create and analyze a Markov model that incorporates all data
from Steps 1-3 to determine the incremental cost-effectiveness ratio for each treatment strategy. We will also
determine financial hardship and service utilization from a patient perspective in order to understand the depth
of impact of these therapies on patients and families. The results of this K23 study will provide context for the
affects of each treatment on patients' health, quality of life, finances, and the health system in a way that will aid
individual decision-making by predicting the optimal treatment strategy. These findings will ultimately serve as
the basis for tools to stratify disease severity and prognostic risk as well as create a scientific methodology to
study other pediatric diseases.

Public health relevance
Narrative: The overall goal of this project is to perform a cost-effectiveness analysis to determine long-term clinical and health economic outcomes of alloHCT for children with sickle cell disease using prospective data. This data will provide additional decision-making tools to patients, parents, and providers in choosing between conventional therapy and alloHCT, with or without a sibling donor, in a comprehensive manner.